The Regulation and Function of the Ubiquitin-Sensing Kinase TNK1

PROJECT SUMMARY/ABSTRACT
Alterations in kinase signaling underlie many of the most devastating human diseases, including
degenerative disease, autoimmunity and cancer. Thus, not surprisingly, kinases are the second most
targeted group of drug targets (next to G-protein coupled receptors). Yet despite their importance in
disease, only about 8% of kinases are targets of FDA approved drugs and roughly a quarter of the
634 kinases in the human kinome is still considered ‘understudied’, leaving over 100 kinases
untapped as potential therapeutic targets and without clear biological functions. This proposal focuses
on TNK1, a poorly understood member of the ACK kinase family of non-receptor tyrosine kinases
(NRTKs). Our recently published data (Nat. Comm. 2021) uncovered the first mechanism of regulation
and the unusual presence of a ubiquitin-association (UBA) domain on this kinase. Critical gaps
relating to this mechanism and the still unknown cellular function of TNK1 are addressed in this
proposal. Our long-term goal is to discover mechanisms of cell growth and survival that can be
therapeutically targeted in disease. The overall objectives of this proposal are to establish the first
detailed mechanism and function of this understudied kinase. The central hypothesis is that the
binding of the TNK1 UBA domain to clusters of poly-ubiquitinated proteins at ubiquitin-rich
condensates acts as a form of induced proximity to oligomerize and activate TNK1 (aim 1). We also
hypothesize that the interaction of 14-3-3 with phospho-Ser502 of TNK1 inhibits TNK1 oligomerization
and conceals the UBA domain, thereby sequestering TNK1 away from ubiquitin in an inactive state
(aim 2). Finally, we posit that TNK1 senses the accumulation of poly-ubiquitin to phosphorylate
substrates that promote the lysosomal degradation (aggrephagy) of ubiquitin-rich condensates (aim
3). The proposal is significant because it fills a basic gap in our understanding of TNK1, provides a
framework to understand how mutations activate TNK1 in disease, and will inform pharmacological
strategies that take advantage of our recently developed TNK1 inhibitor to target TNK1 in disease.
The proposal is innovative because it addresses a novel mechanism of kinase activation through
direct interaction with poly-ubiquitin, thereby establishing ubiquitin-rich condensates as organizing
platforms for TNK1/kinase signaling.

Public health relevance
PROJECT NARRATIVE The research proposed here is relevant to public health because it seeks to gain the first comprehensive understanding of the understudied kinase and potential therapeutic target TNK1. From a translational perspective, the work proposed will inform how we develop our novel TNK1 inhibitor for clinical use. The aims of this proposal are pertinent to the NIGMS goal of understanding fundamental mechanisms of cell biology.